Training in Demography

Summary/Abstract
The Population Studies and Training Center of Brown University requests continuing support for its T32
National Research Service Award. The long-term goal of the PSTC Demography Training Program is to
prepare predoctoral and postdoctoral social scientists to become internationally-renowned population
investigators and scholars. More concretely, our objectives are to promote research, publication, and grant
funding among trainees during and after training. We request support for five doctoral trainees and one
postdoctoral trainee. In this application, we provide evidence of a strong interdisciplinary training program,
supported by productive, committed faculty, focused on training doctoral candidates and postdoctoral fellows
from Anthropology, Economics, Sociology, and Public Health. We demonstrate that the PSTC T32 training
program shows ample evidence of continued intellectual and organizational evolution, dynamic synergy across
disciplines and career stages, from new trainee through senior scholar, and a commitment to excellence that
will produce the highest quality population science scholars. We show excellent recruitment, retention and
placement outcomes in the previous grant period, and we focus on maintaining this excellence while improving
professionalization and enhancing young scholars’ paths to future independence with this new application.
The PSTC training program proposed here builds on a dynamic research infrastructure, with recently
reconfigured thematic foci reflecting dramatic growth in Center and training program faculty. The PSTC has
three signature institutional features: Anthropological Demography; Spatial Inquiry; and International
Demography. The PSTC makes distinctive intellectual contributions in each of five primary research areas:
Migration and Urbanization; Demographic Change and Economic Development; Children, Families, and
Health; Reproductive Health and HIV/AIDS; and Population and Environment. Predoctoral and postdoctoral
trainees are integrated into all institutional features and research areas. Their training is advanced through
coursework, mentorship, working groups, a proseminar, colloquia, methods modules, and professionalization
workshops. We show evidence of major institutional support in the form of physical space, significant
investments in graduate education generally, and targeted funds to support trainees. An active Training
Committee supervises the design of the program, coordinating with our affiliated departments. Co-PDs Qian
and White with PSTC Assistant Director Wildman provide extensive support for the day-to-day operation of the
program. We describe both continuing and innovative organizational and pedagogical efforts to secure the
training goals we outline in this application.

Public health relevance
Project Narrative Our training program mentors social scientists at the predoctoral and postdoctoral levels to become independent population investigators and scholars conducting ethical empirical research to understand and improve global population health and well-being through articulating the critical contributions of the demographic, social, institutional, and environmental dimensions. The program actively recruits a diverse body of trainees to improve the representation of women, underrepresented minorities, and other groups in the public health workforce.